PRIMARY BREAST CANCER THERAPY GROUP--NSABP

As a participting institution in the Primary Breast Cancer Therapy Group (NSABP) we are contributing data from patients entered into the various group protocols. Patients have been entered into Protocol 5, which compared L-PAM with L-PAM and 5-FU, and Protocol 8, which compared the worth of 3 drug chemotherapy (L-PAM, 5-FU, and MTX) with a 2 drug chemotherapy (L-PAM and 5-FU). Protocol No. 6: A trial to compare the worth of segmental mastectomy with and without breast radiation with total mastectomy plus axillary dissection. All patients will undergo axillary dissection and those with histologically positive axillary nodes will receive adjuvant chemotherapy. Protocol No. 9: A trial to determine whether the anti-estrogen Tamoxifen when combined with chemotherapy improves the results obtained with chemotherapy alone. In addition, the NSABP has implemented adjuvant protocols for primary colon and rectal carcinoma. The present application seeks funding (a) to permit continued patient accrual in on-going protocols, (b) to continue follow-up of patients entered into protocols which have terminated, and (c) to collect appropriate biological material and information relevant to such protocols. Finally, the aim of this proposal is to enhance the multidisciplinary approach of this institution in these clinical trials.